IA ERPS Cooperative Agreement

ERPS Project Summary
Given the large impact of Iowa's egg handling industry, providing high quality inspections based on
the scientific principles of feed/food safety is paramount to protecting Iowans and consumers
throughout the nation and world. Furthermore, the federal governments continues to focus on food
safety nationally as demonstrated by the passage of the Food Safety Modernization Act (FSMA).
Similarly, within Iowa we have found an added interest in food safety.
The Bureau has identified that we will be no longer able to keep up with the growing number of
questions and requests to provide assistance and speak to various groups regarding egg safety. As
part of the ERPS cooperative agreement option, the Bureau is requesting funding to craft the
documents needed for ERPS compliance, for training of personnel, and to conduct outreach and
public education. Continuous improvement in Egg Safety and Quality is absolutely essential to meet
the needs of Iowans. However, the State's resources are currently not adequate to respond to the
growing needs of egg handlers and consumers across Iowa.
The Bureau anticipates participation in this cooperative agreement will result in significant
enhancement in the quality of inspections and inspectors egg and bio-security knowledge for Iowa's
egg handling facilities. This will be obtained by the following:
• The State will achieve and sustain significant to full conformance with the Egg Safety
Regulatory Program Standards (ERPS).
• The State has and will continue to actively engage through an annual face-to face meeting (if
applicable) and participation in committees supporting ERPS.
• The State will collaboratively develop strategies and share those strategies with FDA, States,
Counties and local agencies.
• The State will work with FDA establishing the foundation for pursuing regulatory action based
upon the findings of state inspections at state egg handler facilities.
The goal of this project is to attain full conformance with the ERPS within 3 years and to put into
place the tools necessary to allow continuous improvement and to ensure continued compliance
once the funding is discontinued.

Public health relevance
ERPS Project Narrative Abstract The Bureau anticipates participation in this cooperative agreement will result in significant enhancement in the quality of inspections and inspectors egg and bio-security knowledge for Iowa's egg handling facilities. This will be obtained by achieving and sustaining full conformance with the Egg Regulatory Program Standards (ERPS), engaging in the annual face-to face meeting (if applicable) and participation in committees supporting ERPS, and working with FDA to establish the foundation for pursuing regulatory action based upon the findings of state inspections at state egg handler facilities. We intend to attain full conformance with the ERPS within 3 years and to put into place the tools necessary to allow continuous improvement and to ensure continued compliance once the funding is discontinued.